Friendship Bench for Women Who Use Methamphetamine in Vietnam

PROJECT SUMMARY / ABSTRACT
Mental illness is common among women who use methamphetamine (WWUM). The high comorbidity of
mental health issues and meth use worsens both their mental health and meth use outcomes. We propose to
evaluate the potential of Friendship Bench to be used as a low-threshold, task-shifting mental health
intervention among WWUM in Vietnam—a lower-middle-income country. The specific aims of this research
proposal are to: (1) assess the mental health needs of WWUM in Haiphong, (2) adapt Friendship Bench to the
specific needs of Vietnamese WWUM and (3) assess the feasibility, fidelity, and acceptability of the adapted
Friendship Bench for common mental disorders among WWUM and preliminary indicators of its impact in
improving their mental health and methamphetamine use in a two-arm randomized trial, comparing Friendship
Bench with usual psychiatric care.
The proposed research will support the candidate for this career development award, Dr. Nguyen Thu Trang,
to achieve her long-term career goal to ensure more humane and effective treatment of drug-related issues in
Vietnam and globally. Dr. Trang is a researcher at Hanoi Medical University (HMU), Vietnam. To accomplish
that goal, she will work under mentored guidance to achieve four specific training objectives: (1) to acquire
necessary knowledge in mental health interventions and research, including the identification and management
of common mental disorders and the applicability of the Friendship Bench model; (2) to develop key skills in
conducting research with people who use drugs including theoretically driven, evidence-based systematic
recruitment approaches to hidden populations, community engagement, and the associated concerns related
to research in vulnerable populations; (3) to acquire the skills needed to design and implement randomized
controlled trials for both effectiveness and implementation science research and (4) to develop key skills
needed for a successful research career.
Nguyen Thu Trang is supported by a dedicated mentorship team. Drs. Bradley Gaynes, Professor of
Psychiatry and Epidemiology at the University of North Carolina, Chapel Hill (UNC) and Le Minh Giang,
Professor of Epidemiology and leading researcher in substance use in Vietnam at HMU, will serve as her U.S.-
based and LMIC-based primary mentors. Drs. Vivian Go, Professor of Health Behavior at UNC and William
Miller, Professor of Epidemiology at UNC will provide her with mentorship in implementation science and
randomized controlled trial design and conduct. The research plan has the support of Dr. Ruth Verhey – a co-
developer of the Friendship Bench model and Dr. Byron Powel – a leading expert in implementation strategies.
It also secures support from a community-based organization for women who use drugs in Haiphong who will
be a key partner in the research implementation. The chairman of HMU is committed to provide the candidate
with the resources and protected time necessary for completion of this award.

Public health relevance
PROJECT NARRATIVE The high comorbidity of mental health issues and meth use in women worsens both their mental health and meth use outcomes. We propose to evaluate the potential of Friendship Bench to be used as a low-threshold, task-shifting mental health intervention among women who use methamphetamine in Vietnam – a lower- middle-income country. The study will provide preliminary data for our R01 trial testing the effectiveness Friendship Bench to improve mental health and methamphetamine use outcomes among women who use methamphetamine in Vietnam and help the candidate of this career development award acquire critical knowledge and skills to become an independent researcher.